A Mobile Health Application to Detect Absence Seizures using Hyperventilation and Eye-Movement Recordings

Abstract
Eysz, Inc. is developing a mobile health (mHealth) application and algorithms for diagnosing and monitoring
absence epilepsy remotely. Accurate diagnosis and monitoring of seizures and therapeutic effects are critical
elements of effective epilepsy treatment. Unfortunately, absence seizures are notoriously difficult to identify,
leading to diagnostic delay and difficulty monitoring treatments. The gold standard for diagnosing absence
seizures is video EEG (VEEG), but this method is expensive, limited to clinical settings, and can be hard to
access. The gold standard for monitoring absence epilepsy is patient self-reported data, which studies have
shown to be more than 50% inaccurate. Other strategies for remote monitoring, such as ambulatory EEG, lack
the sensitivity and specificity of VEEG, and can add to the stigma people with epilepsy experience. There have
been no new therapy approvals for absence epilepsy since the 1990s, in part due to the difficulty of measuring
outcomes. Thus, there is a critical need for a remote diagnostic/monitoring tool for absence seizures. Eysz
therefore plans to develop an mHealth app that uses (1) voluntary guided hyperventilation (HV), with (2) eye
movement and facial biometric data to monitor seizure susceptibility and treatment responses in people with
absence seizures. Voluntary HV triggers seizures in >90% of people with absence epilepsy and is a standard
clinical tool to assist in diagnosing and monitoring absence epilepsy. HV has also been shown to be safe and
effective when performed on a daily basis to activate seizures and thereby shorten VEEG monitoring sessions.
Thus, HV offers a promising tool for use in the context of at-home monitoring of seizure activity. Eysz is
developing software and algorithms for detecting seizures using eye movement data, starting with absence
seizures. Eysz proposes to extend the use of video-based eye-tracking (and facial biometric tracking) to a
smartphone-based application that includes software-guided HV. This Phase I proposal focuses on initial testing
of our smartphone-based tool for guided HV and video data collection. The Specific Aims of this project are: 1)
Collect eye-movement and facial biometric data from subjects undergoing HV concurrently with VEEG; 2)
Evaluate the potential for a new “gold standard” metric for algorithm validation to enable mHealth development
in the home environment; and 3) Develop machine learning (ML) algorithms that detect seizures from eye
tracking and facial biometrics data. Eysz aims to demonstrate >75% sensitivity for detection of seizures >7 s in
duration, providing a strong foundation for future evaluation of at-home use of the app and algorithm accuracy
in a larger cohort of patients.

Public health relevance
Narrative Childhood absence epilepsy (CAE) is the most common pediatric epilepsy syndrome, affecting 10–17% of all children with epilepsy. Those with CAE often experience significant diagnostic delay and limited monitoring due to the difficulty in detecting absence seizures, which also limits clinical studies of new anti-epileptic drugs in this patient population. An in-home diagnostic method would reduce the wait times associated with in-clinic VEEG appointments, potentially reducing time-to-diagnosis and improving access, especially in rural and low-income areas.